Pediatric Adolescent Virus Elimination (PAVE) Martin Delaney Collaboratory

Abstract
This proposal is highly innovative because it makes available unique resources of the NIH
Clinical Center and intramural NCI programs to the only national and international Martin
Delaney Collaboratory (MDC), the Pediatric Adolescent Virus Elimination (PAVE) MDC
dedicated to pediatric HIV cure research. NIH-PAVE collaboration leverages expertise and
networks in PAVE to identify obstacles to protocol participation in groups currently under-
represented in cure research in the U.S., to recruit such individuals into studies at the JHU and
the NIH Clinical Center, to perform in-depth reservoir characterization with novel tools and to aid
with recruitment into studies of HIV cure. It represents the first nationwide protocol to recruit
young adults with perinatal HIV infection to study HIV reservoirs using contemporary
immunologic and virologic techniques and will establish a registry for long-term evaluation of
facilitating future research. The study will conduct new sampling features and combined
immunologic/virologic approaches to characterize the reservoir and rebound viremia. Once
established, ongoing research studies can be supported through existing mechanisms at PAVE
and intramural clinical programs (Maldarelli) and laboratories (Kearney, Maldarelli). There are
already several similar longitudinal studies of HIV infection in adults have been ongoing for over
25 years at NIH (e.g. NIH 97-I-0072/08-I-0221 Maldarelli, current PI; 88-I-0172, Wright current
PI), and have provided invaluable clinical data and samples for seminal achievements in
understanding the long-term effects of ART and the sources of HIV persistence and clonal
expansion, as barriers to HIV cure.

Public health relevance
Narrative We will determine the role of immune mechanisms in driving HIV persistence, elimination, or expansion of HIV infected clones, and determine whether immune selective pressures shape clone size and composition in young adults in the U.S. living with perinatal HIV-1. In this protocol, we will determine whether the reservoir properties are similar in individuals who acquire HIV with immature immune systems. By identifying and overcoming obstacles to engagement of underrepresented populations, this project advances the overall goal of improving equity and justice in participant selection for clinical studies, which has important impact on relevant strategies for HIV cure research in this population.